22nd Liver Sinusoid Meeting

ABSTRACT
This R13 application requests support for the 22nd Liver Sinusoid Meeting from the International Society for
Hepatic Sinusoidal Research (ISCHS), to be on April 24-26, 2024, in the College of Medicine at the University
of Illinois at Chicago. The application requests support from NIAAA and NIDDK for the participation of trainees
and non-funded early-stage investigators (ESI). The goal of the Liver Sinusoid Meeting is to bring together an
international group of multidisciplinary scientists, including established and new investigators, pre- and post-
doctoral trainees, who are interested in the common questions: 1) how hepatic sinusoidal liver cells and their
crosstalk, contribute to the pathogenesis and resolution of alcohol-associated liver disease (AALD), non-
alcoholic fatty liver disease (NAFLD), fibrosis, stimulation or suppression of liver regeneration, regulation of
liver microcirculation, and hepatocellular carcinoma (HCC) onset and progression; and 2) how new knowledge
from emerging tools applicable to all areas of liver research, such as multiomics, matrisomics, bioengineered
liver tissue, organoids, nanotechnologies, and immunomodulation can be used to improve treatments of liver
disease. Participants at the meeting will present cutting-edge, high-quality research, which begins to identify
novel molecular and cellular interactions within the liver sinusoid. There are surprising gaps in our
understanding of this basic unit of functional activity in the liver; advances in hepatic sinusoidal cell biology are
critical to understanding the cellular basis of AALD, acute, and chronic liver disease. The ISCHS represents
the only international organization, which gathers leading investigators in liver biology and hepatocellular cross
talk from around the world. This meeting will facilitate and promote: 1) international collaborations among
different countries with populations differing in their genetics and social backgrounds who suffer from AALD,
acute, and chronic liver disease; 2) resource sharing among international investigators, generating synergy
and unique ideas; and 3) interaction of trainees at the international level. Taken together, the unique
environment of the Liver Sinusoid Meeting is an ideal format for cutting-edge interactions on the potential
implications of their research into the pathogenesis of AALD, acute, and chronic liver disease, helping to
synergize research that will fill these gaps and advance the frontier of research in liver disease, and
development of preventative and therapeutic treatments.

Public health relevance
PROJECT NARRATIVE This application seeks support from NIAAA and NIDDK to organize the 22nd Liver Sinusoid Meeting, to bring together scientists interested in the function of the cells of the hepatic sinusoid in health and disease. Advances in hepatic sinusoidal cell biology are critical to understanding the cellular basis of alcohol-associated, acute, and chronic liver disease. By providing a forum for experts from many disciplines to discuss the problems related to these diseases and share their latest data, new scientific questions and directions in the field are likely to emerge; ultimately, these will lead to scientific breakthroughs that will define new treatments for liver disease.